Examining the Feasibility of Implementing a Hypertension Storytelling among African Americans with Hypertension

PROJECT SUMMARY/ABSTRACT
Storytelling interventions for chronic disease, are described as personal narratives of living with the health
condition. Previous storytelling interventions have been effective in promoting healthy behaviors and lifestyle
change. For hypertension, storytelling interventions have contributed to reductions in blood pressure among
and increased uptake of lifestyle and behavioral change. Groups traditionally underrepresented in health
research and interventions, may not have access to innovative lifestyle interventions, but these communities
often have the greatest need for access to health interventions. Our preliminary work includes the Penn State
Clinical and Translational Science KL2 funded project titled Developing a Storytelling Intervention for African
Americans with Hypertension. During the KL2 project, nine African Americans with hypertension receiving care
at a Federally Qualified Health Center, were filmed sharing their stories of managing hypertension and sharing
helpful tips for lifestyle changes to manage hypertension. Our proposed intervention will consist of three
groups: 1) usual care 2) Storytelling (storytelling + educational information) accessed using a study website 3)
Storytelling Plus (group storytelling sessions + peer-led educational sessions and goal setting). Peer health
coaching has been a successful approach for promoting healthy behaviors and can be easily integrated into a
safety-net setting. We hypothesize that incorporating Peer Health Coaches into the storytelling intervention will
bolster the engagement with a storytelling intervention. Delivering the intervention using a study website
increases the accessibility of the intervention and allows the participant to view study materials at their
convenience. The outcomes for the proposed study are 1) to assess the feasibility of implementing the
Storytelling and Storytelling Plus interventions by assessing recruitment, retention, acceptability, and fidelity
and 2) the preliminary impact on self-reported medication adherence and blood pressure. The long-term goal
of this project is to develop storytelling interventions that can be integrated into the clinical workflow of a FQHC
and can potentially be disseminated to other FQHC and safety-net settings to promote healthy behaviors and
lifestyle change among African Americans with hypertension.

Public health relevance
PUBLIC HEALTH NARRATIVE The burden of cardiovascular disease is the highest in minority and socioeconomically disadvantaged communities. Lifestyle and behavioral interventions that have demonstrated effectiveness in improving blood pressure and medication adherence may not be available and accessible to individuals living in socioeconomically disadvantaged communities. Storytelling, peer health coaching, and web-based interventions are promising evidence-based approaches for promoting behavioral change. Combining these approaches may enhance the efficacy of an intervention and may offer a sustainable approach for promoting lifestyle change.